CORE--SCIENTIFIC

The purpose of the Scientific Core is to make a data set rich in information about substance use, risk and protective factors, and other variables readily available to the five individual research projects in the proposed Center, so that important questions about drug use can be addressed by means of state-of-the-art methodological procedures. From 1986 to 1992 the NIAAA-funded Adolescent Alcohol Prevention Trial (AAPT) study collected data on substance use, risk factors, and numerous other variables on four cohorts of Southern California schoolchildren (approximately 12,000). Data were collected annually during the junior high and high school years. The AAPT participants are now entering young adulthood. The result will be a cohort-sequential data set on individuals ranging in age from ten to approximately 19. This data set will provide an exciting opportunity for the five individual research projects to examine risk for substance abuse across adolescence.